Professional Development Core

ABSTRACT – PROFESSIONAL DEVELOPMENT CORE
Effective research mentoring relationships are critical to developing the next generation of researchers. The
overall objective of the University of Michigan (UM) Kidney, Urology, and Hematology Research Training
Network (KUHR) Professional Development Core is to develop and support, activities and curricula designed
to enhance trainee competitiveness in research. Importantly the core also includes programs to enhance
preceptor training and continued improvement. Through the Professional Development Core activities, trainees
and preceptors will learn how to improve these research mentoring relationships at all career stages and
across the entire spectrum of research from bench to bedside to promote cultural change that values
excellence and equity and inclusion in research mentoring as a critical aspect of diversifying the research
workforce. As such, formal training in mentorship, career development and team science are critical to the
successful transition from mentored training to independent research. The UM KUHR Professional
Development Core will enhance leadership, team building and career development for both trainees
and preceptors through completion of the following specific aims: Specific Aim 1: To achieve enhanced
trainee competitiveness in research. Trainees will complete program curricula that will enhance their skills in
identifying the most relevant scientific questions and approaches to solve/tackle them, making effective
presentations, both written and oral and overall communication and develop an effective professional network.
This includes the following activities: 1) Responsible Conduct of Research Training, 2) Rigor and
Reproducibility Training 3) Career Development Activities, 4) Specialty Training/Technical Skills, and 5)
Pedagogical Training in Teaching. Specific Aim 2: To develop and support effective mentoring by
preceptors. Program Faculty Preceptors will complete program curricula that will enhance their skills in
effective mentoring and includes the following activities: 1) Mentoring Academy, 2) Mentoring Forum, 3)
Culturally Aware Mentorship Training, 4) Pedagogical Training in Teaching, and 5) Diversity, Equity, and
Inclusion Training.